Lipid Metabolism as a Determinant of Ferroptosis Sensitivity in Cancer

Project Summary
Ferroptosis, a cell death process driven by iron-dependent phospholipid (PL) peroxidation, has emerged as an
active research field with its publication number doubling annually since the concept was introduced and the
term was coined by Dr. Stockwell in 2012. Ferroptosis plays a crucial role in various diseases. In cancer biology,
ferroptosis has been implicated as an endogenous tumor suppressive mechanism and its induction is being
explored as a uniquely effective therapeutic approach for aggressive, drug-resistant cancers. Remarkably,
cellular metabolism, particularly lipid metabolism, plays a central role in the execution of, surveillance of, and
evasion from, ferroptosis. In this program, three highly integrated projects seek to determine the roles, regulation,
and underlying mechanisms of lipid metabolism in ferroptosis and to explore novel cancer therapeutic
approaches based on the elucidated mechanisms. Project 1, “Phospholipid remodeling in ferroptosis and
cancer”, led by Dr. Xuejun Jiang (Memorial Sloan Kettering Cancer Institute), investigates how multiple
phospholipid-modifying enzymes dictate ferroptosis sensitivity through specifically rewiring cellular phospholipid
profiles and how these events are regulated by cancer signaling. Project 2, led by Dr. Brent Stockwell (Columbia
University), "Targeting specific lipid species that drive ferroptosis resistance", centers on roles and biogenesis
of two specific lipids in driving resistance of cancer cells to ferroptosis. Project 3, “PHLDA2–mediated
phospholipid oxidation in ferroptosis and tumor suppression”, led by Dr. Wei Gu (Columbia University Medical
Center), explores a unique and noncanonical phospholipid peroxidation process that drives ferroptosis in some
cancers. One Shared Resource Core (SR Core) (Leader: Dr. Brent Stockwell, “Ferroptosis biomarkers and
lipidomic analysis”) will support all these projects by performing essential lipidomic and ferroptosis biomarker
analysis in cellular models and in vivo models. The proposed projects are based on extensive and collaborative
preliminary studies; in all three projects, novel cancer therapeutic approaches based on the elucidated
mechanisms will be tested by using genetically engineered and xenograft mouse models, including patient-
derived xenograft (PDX) models with clinically relevant genetic backgrounds. Overall, the proposed program will
define key mechanisms by which cancers modulate ferroptosis through lipid metabolism and will provide novel
approaches for the development of ferroptosis-induction-based cancer therapeutic strategies for targeting
aggressive malignancies, with a special focus on breast and liver cancers.

Public health relevance
Project Narrative The proposed program will define mechanisms for the regulation of ferroptosis by lipid metabolism and provide novel insights into the development of ferroptosis induction-based cancer therapeutic approaches.